Investigating the role of oxygen on Plasmodium multiplication rate

Plasmodium falciparum (P. falciparum) and Plasmodium knowlesi (P. knowlesi) are protozoan pathogens that
cause malaria. Of the five species of Plasmodium that infect humans, P. falciparum and P. knowlesi both involve
the sequestration of parasitized red blood cells in the deep tissue microvasculature and both cause a range of
disease severity. The goal of the proposed study is to understand how fluctuations in the oxygen concentration
in the microenvironment, which varies across tissue sites in the body, affect the multiplication rate of P.
falciparum and P. knowlesi. The findings from this study are significant toward our understanding of antimalarial
drug resistance, as some of the most important antimalarial drugs have been shown to work by triggering
increased reactive oxygen species (ROS) in the parasite, and in vitro studies of drug-resistant Plasmodium under
different oxygen concentrations have shown variable results. While it is well-known that Plasmodium grows best
in the laboratory under low oxygen conditions, little is known about the biology of the parasite under higher
oxygen conditions. Our preliminary in vitro data suggests that P. falciparum replicates significantly slower at 13%
oxygen (mimicking the oxygen concentration in lungs and liver) versus 1% oxygen (mimicking the oxygen
concentration in brain and bone marrow). Confocal imaging suggested lower mitochondrial activity in the 13%
condition. Here in Aim 1, we will characterize the cellular and molecular mechanism(s) underlying the variability
in multiplication rate under different oxygen conditions, studying this phenomenon in diverse species and strains
of Plasmodium. We hypothesize that as oxygen in the microenvironment increases, an increase in intracellular
ROS and cellular damage follows, leading to a decline in multiplication rate. In Aim 2, we will directly test whether
the parasite’s redox balance affects Plasmodium multiplication rate, through manipulation of ROS and P.
falciparum’s glutathione antioxidant system. While much focus exists on characterizing genetic mutations
underlying drug resistance, very little work explores the host environmental factors that may also play a role in
the redox balance of the parasites, which may in turn contribute to antimalarial drug efficacy in vivo.

Public health relevance
Malaria is a disease caused by a protozoan parasite that replicates within the vasculature of multiple organs including those with lower oxygenation (e.g., brain, bone marrow) and those with higher oxygenation (e.g., lung, liver). While laboratory-based studies suggest that malaria parasites grow fastest in environments with low oxygen, much less is known about their growth in highly oxygenated environments. This research will help us understand how tissue oxygenation may affect the malaria parasite’s replication rate and susceptibility to antimalarial drug treatment.